LIPOPROTEIN LIPASE AND HEPATIC LIPASE ACTIVITIES

Utilizing an assay for lipoprotein lipase and hepatic lipase developed by Dr. Frost, this protocol will define the activities of these two enzyme species in the post-heparin plasma of normal and hypertriglyceridemic individuals. The relationships (if any) of these activities to the concentrations of serum very-low-density and high-density lipoproteins, and to the personal and family history of manifest atherosclerosis will be examined.